Administrative & Mentoring Core

Administrative & Mentoring Core – Project Summary
The Administrative & Mentoring Core (Admin Core) is responsible for the leadership, integration and
successful operations of the COBRE in Digestive & Liver Disease (CDLD). The Core is directed by Stephen A.
Duncan, D.Phil, CDLD Program Director, with assistance from Don C. Rockey, MD, CDLD Associate Director,
who form the Executive Committee along with the CDLD Core Leaders and Primary Mentors. An Advisory
Committee of two internal senior institutional leaders and four external eminent scholars will provide objective
oversight, evaluation, and strategic interactions to optimize the Center’s impact. The Specific Aims of the
Admin Core are: 1) Implementation of the CDLD Overall Plan; 2) Mentoring and Faculty Development; 3) Pilot
Projects Program; 4) Biostatistical Support; and 5) Center Evaluation.